Pilot Project Program

The CURES Pilot Project Program is intended to provide both initial support to new investigators to enable them to establish their environmental health research programs and supplemental support to established investigators to enable them to pursue innovative new ideas that broaden or depart from their current research programs. The Pilot Project Program also serves to encourage investigators in different disciplines to apply their research expertise to an environmental health problem, thereby broadening the knowledge and skill base of CURES. Additional goals of the Pilot Project Program are to provide an effective mechanism for attracting new members to CURES and to promote career development, especially of new investigators. The Pilot Project Program is an essential component of the CURES process for accomplishing its goals to build capacity to enhance our understanding of the adverse health effects from complex chemical and nonchemical urban environmental exposures; develop the next generation of environmental health researchers who are facile with transdisciplinary, translational team science; and interact with the community so as to leverage our research to improve the health of the people of Detroit. The specific aims of the CURES Pilot Project Program are: 1) Plan each year's Pilot Project Program funding opportunity based on input from our community advisors and CURES program leaders, advertise the availability of CURES pilot awards, provide guidance to potential applicants, and coordinate the submission and review of applications. 2) Award 3-6 new pilot projects each year, with each award for $65,000 over a 1.5-year period. 3) Use the Pilot Project Program as a mechanism to support the career development of new investigators. 4) Monitor pilot projects during the pre-award, award- time, and post-award phases. The Pilot Project Program Leader, Career Development Co-Leader, and Integrative Health Sciences Facility Core Co-Leader will serve as the core members of an advisory team that will meet regularly with CURES pilot project recipients to review progress and provide guidance. 5) Track the success of the Pilot Project Program. The primary measure of success of the Pilot Project Program is the extent to which pilot projects generate extramurally funded projects. Additional measures of success will be publication or presentation of research findings resulting from the pilot project and successful career advancement of pilot project recipients.